Bioenergetics Core

Project Summary – Bioenergetics Core
Bioenergetic measurements using contemporary live-cell metabolic assay platforms provides insights into
various parameters of energy metabolism. Complemented by established flow cytometry assay platforms to
measure different mitochondrial and cellular functional parameters, the Bioenergetics (Bio-E) core will form a
key component of Arkansas Integrative Metabolic Research Center (AIMRC). The Bio-E core will be a new core
created to meet the metabolic research needs of the proposed COBRE center. The Bio-E core will coordinate
closely with the AIMRC Imaging and Spectroscopy and Data Science Cores to generate a cross-disciplinary
framework and allow project leaders to shed new light on cell and tissue metabolism, thus enabling novel
discoveries, as well as clinical translation of such discoveries. Close collaborative interactions between the Bio-
E Core and COBRE project leaders as well as the Imaging and Spectroscopy and Data Science Cores will lead
to new innovations in research methods that will benefit future COBRE investigators as well as the broader
campus research community. Hands-on training in live-cell metabolic assays and flow cytometry technologies
will be provided to Center members, the campus and biomedical researchers in Arkansas.